System-independent quantitative cardiac CT perfusion

System-independent quantitative cardiac CT perfusion
Phase II, SBIR
Summary
BioInVision, Inc. and team - Case Western Reserve University (CWRU) biomedical engineers and University
Hospitals Cleveland Medical Center (UH) imaging cardiologists - will develop software for quantitative analysis
of cardiac CT perfusion (CCTP) data, creating an important tool for evaluation of cardiovascular disease. With
this product, cardiologists will be able to identify functional flow deficits in coronary artery territories. When one
combines functional myocardial blood flow (MBF) function with coronary anatomy from coronary computed to-
mography angiography (CCTA), it provides needed information on the physiologic significance of a stenosis.
The CCTP+CCTA combination could provide an ideal gateway exam for deciding whether to send a patient for
percutaneous invasive coronary angiography and potential intervention (e.g., stenting). In addition, low flow with-
out the presence of a stenosis suggests microvascular disease, a very prevalent ailment of growing concern,
especially among women and diabetes patients. CT compares favorably to all other non-invasive cardiovascular
imaging techniques (SPECT, PET, and MRI). It is available in many settings, including emergency departments,
and is high throughput as compared to other methods. It provides both MBF and reliable coronary anatomy, with
are unavailable in any other single modality, providing a unique ability to non-invasively discriminate cardiac
microvascular disease. It has excellent resolution enabling detection of endocardial perfusion deficit, thought to
be an early disease indicator that is impossible to assess with SPECT. CT is cheaper and has higher patient
throughput than MRI or PET. With the inclusion of MBF, CT would have an excellent opportunity to disrupt the
diagnostic pathway leading to percutaneous intervention, a pathway which has been dominated by SPECT my-
ocardial imaging, a modality that gives zero information about coronary anatomy. To achieve reliable, accurate
CT MBF measurements, we will invoke innovations to reduce beam hardening and to make reliable flow esti-
mates. Currently, CT perfusion is done on different CT machines with manufacturers’ proprietary software, using
algorithms that can give erroneous MBFs. Applicable to any commercial scanner; our solution would harmonize
measurements across acquisition systems providing trustworthy, standardized measurements to clinicians,
thereby improving management of cardiovascular patients.

Public health relevance
Narrative We will develop software to enable reliable evaluation of blood flow in heart tissue using CT imaging. With suc- cess, our project could lead to an improved gateway examination that could reduce unnecessary invasive coro- nary angiography, thereby reducing costs, patient discomfort, patient risk, and possibly unnecessary interven- tional therapies.